Safeguarding Genetic Resources of Aquatic Biomedical Models

PROJECT SUMMARY/ABSTRACT
The NIH-funded aquatic model stock centers have expressed concerns over growing needs for them and their
associated research communities to use germplasm repositories in preservation and sharing of genetic
resources. Because of a lack of comprehensive repository capabilities, the National Xenopus Resource (NXR),
Ambystoma Genetic Resource Center (AGSC), and National Resource for Aplysia (NRA) face many challenges
such as the risk of losing valuable genetic lines. In the ongoing R24 project (2020-2024) we have developed or
improved practical approaches for sperm cryopreservation for NXR and AGSC, and we are making breakthrough
progress in embryo and larvae cryopreservation for NRA. For Xenopus, we developed a standardizable,
streamlined pathway which is scalable and substantially improves throughput and quality assurance. For
Ambystoma we developed a de novo cryopreservation protocol and expanded it into a functional pathway which
produced a 50% fertilization rate with thawed sperm. For Aplysia, we have recently achieved short-term (>10 hr)
post-thaw survival of free-swimming larvae by vitrification. During this project, we have collaborated closely with
the stock centers and responded to their needs through hundreds of interactions including site visits, training
visits, phone calls, remote meetings, and workshops. In addition, we have developed a central “Hub” at the
Aquatic Germplasm and Genetic Resource Center (AGGRC) that supports resource sharing among the stock
centers, the USDA National Animal Germplasm Program, and user communities leading to the creation of a NIH
Aquatic Biomedical Germplasm Repository Network. In sum, the ongoing Hub R24 project has developed basic
reproductive and cryopreservation protocols and customized these based on the specific resources and needs
of the stock centers. Based on this success, the overall goal of this proposed renewal R24 Hub work is to advance
the capabilities at the resource centers from feasibility establishment to operational repositories with high-
throughput production and routine quality management programs. Proposed translational research will focus on
building practical capabilities at the stock-center level for amphibians; expanded fundamental research and
characterization will proceed at the AGGRC for Aplysia, and resource sharing platforms will be established at
the stock center and research community levels. To facilitate resource sharing and distribution, we will advance
the NIH Aquatic Biomedical Germplasm Repository Network from proof of concept to establishment of formal
operations. This will ensure that research communities will have access to valuable genetic lines that may
otherwise be at risk of being lost. The specific aims are: 1) Develop high-throughput sperm cryopreservation
pathways and quality management programs for operational repository capabilities at NXR and AGSC; 2)
Develop operational repository capabilities for early life stages of Aplysia sea hares and the algae species
required for Aplysia feeding and larval development, and 3) Advance the AGGRC Hub and NIH Aquatic
Biomedical Germplasm Repository Network to facilitate resource management, sharing, and distribution.

Public health relevance
PROJECT NARRATIVE: The NIH-funded aquatic model stock centers have expressed growing needs for them and their associated research communities to use germplasm repositories in preservation and sharing of genetic resources. Because of a lack of comprehensive repository capabilities, the National Xenopus Resource (NXR), Ambystoma Genetic Resource Center (AGSC), and National Resource for Aplysia (NRA) face many challenges including the risk of losing valuable genetic lines, inefficiency of maintaining living animals, and the struggle to meet increasing demands from their research communities. Based on the success of the ongoing Hub R24 that has developed basic cryopreservation protocols and customized these based on the specific resources and needs of the stock centers, we propose to advance the capabilities at the resource centers from feasibility establishment to operational repositories with high-throughput production and routine quality management programs, and to advance the Aquatic Germplasm and Genetic Resources Center (AGGRC) Hub and NIH Aquatic Biomedical Germplasm Repository Network to facilitate resource management, sharing, and distribution.